Novel Mechanisms of ROS/RNS Signaling Underlying Castration-Resistant Prostate Cancer Emergence and Progression

Abstract
Castration-resistant prostate cancer (CRPC), a fatal disease, remains therapeutically underserved due
to limited understanding of molecular factors underlying its emergence and progression. Through unbiased
transcriptomics analysis of an early CRPC model developed in our lab and patient dataset analyses, we have
discovered that stimulation of the nitric oxide receptor complex, soluble guanylate cyclase (sGC), in conjunction
with standard-of-care androgen deprivation (AD) is likely to be therapeutically beneficial in CRPC. Based on our
preliminary results, our hypothesis is that decreased sGC activity promotes CRPC growth and that increasing
sGC activity will limit CRPC emergence and progression. The rationale of our studies, supported by our findings
and well-characterized sGC regulatory mechanisms from the cardiopulmonary field, is that sGC is oxidized and
refractory to stimulation in CRPC but is functionally regenerated by AD-induced redox-protective responses.
Thus, the combinatorial use of sGC agonists and AD is predicted to be an effective strategy to combat CRPC.
The sGC agonist, riociguat, is FDA-approved as a vasodilator in pulmonary hypertension treatment. Our
preliminary data show riociguat reduces xenograft CRPC growth. This anti-tumor response is accompanied by
lowered PSA levels as well as increased systemic and intratumoral cyclic GMP (cGMP) levels, indicating on-
target stimulation of sGC bioactivity. Consistent with the physiologic function of enhanced sGC activity, we find
riociguat treatment leads to marked tumor oxygenation and decreased levels of CD44, a key PC stem cell
marker. Thus, riociguat efficacy may derive from eradication of hypoxic niches and the residing androgen-
refractory stem cell populations thought to underlie CRPC. Hypoxia also alters the tumor redox state through
mitochondrially-generated ROS that regulate angiogenic signaling. Through its putative targeting of cancer stem
cells and redox vulnerabilities, riociguat is novel in PC therapy, and is safe and well-tolerated longterm. Our
objective is to comprehensively establish mechanisms underlying how and why stimulating the sGC pathway
limits CRPC growth and progression. Therefore, in these studies, we will assess 1) how mechanisms that control
sGC expression and regenerate oxidized inactive sGC are altered in hormone-sensitive vs. castration-resistant
cells, 2) how enhancement of sGC bioactivity induces anti-CRPC outcomes through consideration of hypoxia-
associated metabolic and redox stresses, including those induced by androgen receptor re-activation under AD,
and 3) test riociguat efficacy in the spectrum of CRPC disease, using robust preclinical and patient-derived
models encompassing emergence, growth, progression and metastatic bone colonization. We will validate key
molecular findings in de-identified PC patient specimens. Our studies possess strong potential to uncover novel
mechanisms underlying PC progression, and for clinical translation via repurposing riociguat to treat CRPC.

Public health relevance
Project Narrative Castration-resistant prostate cancer (CRPC), a leading cause of cancer-related deaths in American men, emerges following failure of standard-of-care androgen deprivation therapy and leads to fatal disease. Using transcriptome-wide screening of a novel CRPC emergence model developed in our laboratory, we have identified soluble guanylyl cyclase (sGC) as a novel, clinically actionable target in CRPC. Our research will investigate stimulation of sGC activity via riociguat, a repurposed FDA-approved and well-tolerated drug, as a potentially safe and effective approach to reduce CRPC growth and progression.